Role of Etv4 and Etv5 in the self-renewal and differentiation of nephron progenitors

Abstract:
Etv4 and Etv5 (Etv4/5) are two transcription factors expressed in the developing mouse kidney, specifically in
the ureteric bud tips, the metanephric mesenchyme and the renal vesicle.
Our preliminary data using a mouse model of Etv4/5 deletion in the nephron progenitor cells (NPCs) and their
progeny demonstrate a critical role for these transcription factors during nephrogenesis; absence of Etv4/5
cause premature NPC exhaustion, thinning nephrogenic zone and hypoplastic/cystic kidneys at birth. In
addition, these mutants present segmentation defects as early as the s-shape body stage. We have generated
RNAseq data from NPC mutant and littermate control embryonic kidneys and identified Wnt4 as a downstream
target of Etv4/5.
Based on these preliminary data we hypothesize that Etv4/5 modulate nephrogenesis, at least in part, by
downregulating Wnt signaling in the NPCs and in the developing nephron. We further hypothesize that this
downregulation is required to favor both self-renewal of NPCs and differentiation of the early nephron.
We will test these hypotheses in two aims. In aim one we will investigate the crosstalk between Fgfs, Etv4/5
and Wnt4 signaling to promote self-renewal/prevent differentiation of the NPCs. In aim two we will investigate
how Etv4/5 and Wnt4 signaling affect nephron differentiation. These studies will provide further insight into the
signaling network driving progenitor self-renewal and differentiation; they will also expand our knowledge of the
cellular readout of Etv4 and Etv5 expression, therefore having a significant impact not only on the field of
developmental biology but also in cancer and in vitro organogenesis.

Public health relevance
Narrative: Etv4 and Etv5 are required for normal limb, testis, kidney and motor neuron development. In humans they have also been associated with obesity and cancer progression, invasion and metastasis. We aim at elucidating their role in nephrogenesis as well as providing new insight on the mechanisms driving nephron progenitor self-renewal and differentiation.